Effectiveness of Recipe4Health on Obesity and Cardiometabolic Health: A natural experiment

PROJECT SUMMARY
The landmark White House Conference on Hunger, Nutrition, and Health in September 2022 underscored the
urgency of improving food and nutrition security in the US as a fundamental strategy to promoting health
equity. Food insecurity – the lack of consistent access to sufficient quantities of healthy food -
disproportionately impacts communities of color and those with limited resources, deepening existing inequities
with nutrition-sensitive chronic conditions like obesity, diabetes, and heart disease. To address the interrelated
challenges of food and nutrition insecurity and chronic disease, healthcare organizations are increasingly
integrating “Food as Medicine” nutrition interventions into healthcare to treat disease. A recent policy change in
California provides a powerful, time-sensitive opportunity for a natural experiment to evaluate the impact of
“Food as Medicine” in participants compared to controls from the same highly diverse patient population. In
2022, the California Advancing and Innovating Medi-Cal (CalAIM) Medicaid section 1115/1915(b) included a
provision for medically supportive food for Medi-Cal (Medicaid in California) beneficiaries. It is extremely
critical to start the data collection as soon as possible to be able to complete follow-up data collection
before the policy expires. Alameda County, California, home to a diverse community of 1.6 million, has
leveraged this policy change to offer Recipe4Health to Medi-Cal beneficiaries. Recipe4Health is a leading
Produce Prescription model in the US that includes: 1) Produce Prescription (Food Farmacy); 2) Group and
individual health coaching (Behavioral Pharmacy); and 3) Technical assistance to providers for clinical
integration of Recipe4Health. We will use a quasi-experimental design to evaluate the impact of Recipe4Health
on key markers of cardiometabolic health among patients with a BMI30 (e.g. glycemic control and cholesterol)
using two strategies. Strategy 1 will take advantage of BMI and laboratory data available in the electronic
health record (EHR),using our experience with retrospective propensity score matching. Strategy 2 will include
a prospective random subsample (240 participants+ 240 propensity-score matched controls), with
assessments at 0, 3, and 6 months. With this subsample, point-of-care testing at patient homes will support
timely collection of key laboratory biomarkers (HbA1c and cholesterol), and telephone surveys will allow for
assessment of food and nutrition security and high-quality dietary intake data (24-hour recall). We are uniquely
positioned to conduct this study as we have already built bi-directional community partnerships, infrastructure
to share EHR data, and the infrastructure to conduct point-of-care testing. Successful completion of these aims
will represent a large, generalizable, and rigorous assessment of Food as Medicine in a highly diverse low-
income patient population (~50% Latinx, 20% non-Hispanic Black, 10% Asian/Pacific Islander), with direct
relevance to patients, the healthcare system, and policy makers.

Public health relevance
PROJECT NARRATIVE Food security – having consistent access to healthy foods – is important for prevention and management of diet-sensitive chronic diseases such as diabetes. This is especially critical for communities of color who are disproportionately impacted both by food insecurity and diet-sensitive chronic diseases. Policies such as the recent CalAIM Medicaid waiver, which is a recently implemented policy that allows healthcare organizations to be reimbursed for providing healthy food, address this double burden. This study will assess the impact of the CalAIM policy change on food insecurity, diet quality, obesity, and indicators of cardiometabolic risk among diverse patients with obesity.